Genetics of deep-learning-derived neuroimaging endophenotypes for Alzheimer's Disease

Abstract
There is still a lack of knowledge on the key genetic factors associated with post acute syndrome for COVID-19
patients, especially those related to neurological complications. In this study, we will utilize both the genetic
and clinical data available through the All of Us researchers platform to study the genetic association with
COVID-19 complications. In order to more accurately phenotype the patients based on their clinical trajectory
mostly recorded in their electronic health records, we will utilize a pretrained deep learning model trained on
more than four million patients from the N3C cohort. The pretrained model will be further fine-tuned on the All
of US data, and will be used to phenotype the patients with genetic data. Further GWAS study will be
performed to correlate between the deep learning based phenotype and the genetic information. Successful
completion of this project will bring new insights to guide COVID-19 patients treatment to better prevent or
manage further complications.

Public health relevance
ProjectNarrative (Public Health Relevance Statement) There is still a lack of knowledge on the key genetic factors associated with post acute syndrome for COVID-19 patients, especially those related to neurological complications. In this study, we will use AI and deep learning to analyze the genetic and clinical data available through the All of Us researchers platform and identify the genetic factors of post-COVID neurological complications. Successful completion of this project will bring new insights to guide treatment to COVID-19 patients to better prevent or manage further complications.